Shared Resource: Northwest BioTrust

Northwest BioTrust Shared Resource Project Summary/Abstract NWBioTrust (NWBT) is a new established resource that represents the maturation of the Developing Tissue Bank Shared Resource currently funded by the Cancer Center Support Grant (CCSG). The CCSG, as well as two major grants totaling $6.75M from Washington State's Life Sciences Discovery Fund (LSDF), funded much of the early developmental work of NWBT. NWBT is the result of a successful collaboration between the UW departments of Pathology, Laboratory Medicine, and Biomedical Informatics and Medical Education (BIME), the UW Institute of Translational Health Sciences (local CTSA), FHCRC, SCCA and Children's. The mission of NWBT is to provide reliable and cost-effective access to high-quality human tissue, blood and other body fluid samples, and associated clinical and specimen annotation data, for innovative diagnostic, therapeutic and public health sciences cancer research. The resource provides the following services: ? Prospective collection of annotated research-only tissue, blood, and other specimens; ? High-throughput collections of annotated remnant diagnostic materials; and ? Identification of existing annotated repository samples using a Virtual Biospecimen Discovery (VBD) system. NWBT provides an important role to ensure that the well established Consortium cancer repositories acquire and maintain sufficient biospecimens to support a wide range of research studies. NWBT also staffs a fee-for- service office whereby researchers may extract EMR-derived data which may be linked to specimens (either identified, or de-identified via NWBT sample codes, depending on IRB permissions).

Public health relevance
Not applicable to CCSG.